MULTI PHOTON IMAGING OF SEROTONIN AUTOFLUORESCENCE SECRETION IN RBL 2H3 CELL

Multiphoton processes not only act to localize photoactivation to the focal spot but they allow access to high energy transitions not easily accesible by linear processes. We are using three-photon excitation to image the autofluorescence of serotonin-containing secretory granules in RBL-2H3 cells. Because we use red light (which is significantly less harmful than the 220nm wavelengths necessary to excite serotonin using one-photon processes), the cells remain viable and exhibit degranulation kinetics similar to those found using cuvette measurements. Studies at the single cell level suggest previously unknown mechanisms of release. A manuscript of these results is now in preparation.